Lung endothelial cell phenotypes

PROJECT SUMMARY
Endothelium lines blood vessels and interconnects all organ systems. However, endothelial cells exhibit a rich
diversity in structure and function. Such heterogeneity is apparent between endothelial cells in different
organs, in endothelial cells along a single vascular segment within an organ, and between immediately
adjacent cells. This program project grant is founded on the overall hypothesis that endothelium lining
pulmonary arteries, capillaries, and veins is phenotypically distinct, where each cell type is specialized
to fulfill the unique demands of its vascular niche. Specialization among these cells is encoded by discrete
organization of second messenger signaling networks. Therefore, in this competitive renewal each of our
projects examines the organization and function of endothelial cell signaling networks. We evaluate the origin
of second messenger signals, how these signals spread inside of the cell, what limits the lifespan of the
signals, and which effector proteins are principally activated by the signals. For the first time we can measure
three-dimensional spread of second messengers in realistic cellular geometries over time. Bacteria such as
Pseudomonas aeruginosa impair endothelial cell function during the course of infection that culminates in
acute lung injury. P. aeruginosa alters the organization and function of second messenger signaling, and in
some instances, the bacterium utilizes enzymes that generate second messenger signals during the host-
pathogen interaction. P. aeruginosa and its exoenzymes disrupt the endothelial cell barrier, and hence, our
projects use this bacterium and its toxins to probe determinants of endothelial heterogeneity and function,
including barrier integrity. All projects take advantage of vertically integrated approaches, ranging from the use
of cultured cells (e.g. with control for substrate stiffness) to various in situ (e.g. isolated organs, lung slices,
isolated blood vessels, and cell-free lung scaffolds) and in vivo preparations. In each of these cases, attention
is paid to what is similar, and what is dissimilar, about the respective cell phenotypes. Altogether, projects
systematically address three specific aims or objectives, to: (1) identify and test novel molecular mechanisms
(e.g. signatures) that are responsible for site-specific endothelial cell function, especially in the microcirculation,
(2) determine the importance of these mechanisms in preclinical models of disease, and (3) translate novel
therapeutic approaches to preclinical models of disease. Projects are highly interactive. Defining mechanisms
that underlie second messenger signaling networks will not only inform us as to the nature of endothelial cell
heterogeneity, but provide unprecedented insight into host-pathogen interactions that disrupt the endothelial
cell barrier and cause tissue edema. Mechanistic insight into endothelial signal transduction networks will
reveal novel therapeutic approaches to improve endothelial dysfunction.

Public health relevance
PROJECT NARRATIVE Endothelial cells line all blood vessels in the body, and coordinate the communication that occurs between the blood and tissues. Endothelial cell injury or dysfunction is a cardinal feature of vascular disease, making the endothelium an important therapeutic target. However, endothelial cells behave differently in arteries, capillaries and veins, and the molecules responsible for these distinct behaviors represent novel therapies that enable drug targeting to an appropriate vascular location.